In Vitro Analytical Core

Project Summary
The Center for Cell Signaling Research (CCSR) focuses on delineating molecular mechanisms and cellular processes in
aging, stress, bioenergetics, and cellular metabolism, which requires the expertise and instrumentation to study cell-cell
interactions and to delineate intracellular pathways within a given cell type. To support the goals of the CCRS Research
Project Leaders (RPLs), we propose to establish a new In Vitro Analytical Core (IVAC) facility. The IVAC will
provide training, instrumentation, and services for the development, analysis, and storage of in vitro cell models for a
wide range of biological and medical investigations, as well as various types of sample preparations for downstream
analysis. Specifically, the IVAC will focus on the development of a stable cell lines, the performance of transfections that
enables the use of genetically encoded biosensors for functional imaging of biochemical processes, the utilization of a
wide range of protein analysis approaches (gel/blots/well-based/cell-based), and the preparation of samples for
downstream “omics” applications that can be completed by external IDeA cores. The IVAC will be equipped with
instrumentation that is currently unavailable in Maine (e.g. the Thermo Scientific CellInsight CX5, a high content
multiplexable quantitative imager for cellular/subcellular functional examinations, a QuantStudio5 384-well Real-Time
multiplexable PCR machine, and a Thermo iBright 1500FL 5-channel gel/blot imager for multiplex fluorescence
analyses), as well as existing shared resources that are currently not part of a research core. All equipment will be
consolidated into a centralized, newly renovated laboratory. Dr. Ling Cao, a successful alumnus of a previous COBRE
program, will serve as the Core Director and oversees the operation of the IVAC along with a full-time Core Manager and
a Staff Technician. To ensure high-quality services and scientific rigor, the IVAC will 1) establish series of standard
operation procedures, 2) design and implement new training programs for faculty, staff, and trainees, 3) be engaged in
method development/improvement, and 4) grow its collaborations with other core facilities within and outside of UNE.
While keeping RPLs as the IVAC’s priority, establishment of the IVAC will also improve UNE’s research capacity and
create a regional resource thus benefit investigators within and outside UNE. The IVAC will also work towards long-term
sustainability by implementing an efficient online management system, conducting regular evaluations, continuing
professional development, and increasing its regional and national visibility and reputation. In addition, UNE has
committed vital support to the future success of the IVAC, including renovation costs, matching funds for equipment
purchases and service contracts, and additional protected time for the Core Director. The following sequential steps are
outlined to enable us to establish the IVAC and accomplish its mission of enhancing research infrastructure and providing
quality services to support the research programs of the RPLs and other UNE investigators. Aim 1: Establish a functional
IVAC facility; Aim 2: Support RPLs to achieve their project goals through comprehensive services.